ShEEP Request for a Comprehensive Laboratory Animal Monitoring System

Project Summary/Abstract
A Comprehensive Laboratory Animal Monitoring System-Home Cage (CLAMS-HC) provides data
on metabolic changes in research animal models that are key components for investigations of
diabetes, control of appetite, obesity, effects of specific diets, cancer treatment, lung damage,
traumatic brain injury, post-traumatic stress disorder (PTSD), and alcoholism. These topics are
key to ongoing VA-funded research projects with animal subjects at the VA Puget Sound, and of
importance to conditions that harm Veteran health and well-being, and for which better treatments
are sought. Eleven funded VA Puget Sound investigators have approved animal research
protocols that rely on data provided by a CLAMS-HC.
Our station's animal researchers actively make use of a 12-year old CLAMS maintained as a core
resource. This ShEEP request is for a new CLAMS-HC with significantly improved capabilities to
provide additional types of data from animal models that will strengthen the research. The 2020
model CLAMS-HC features new key elements not available in the model we currently own:
standard size rodent housing with bedding substrate contact, measurement of animal weights,
respiratory rate, activity tracking, sleep pattern recording, exercise logging (running wheel time
and distance), liquid intake volume and preference tracking and food preference/choice tracking.
These capabilities are key to the CLAMS-HC utility in working with models of PTSD (to assess
alcohol consumption and preference, changes in sleep patterns and activity levels); for models of
cancer cachexia and sarcopenia (weight changes tied to food consumption and activity levels);
for models of traumatic brain injury (sleep patterns, activity levels, respiratory rate, alcohol
consumption and preference); for models of obesity and metabolism (weight changes, exercise
and food consumption, activity levels) and for models of lung damage (respiratory rate, activity
levels and exercise). The sub-standard-size cages that fit our current CLAMS are too small to
accommodate large rodents needed in studies of diet-induced obesity. The new CLAMS-HC
obtains data from animals housed in the same size cages in which they are normally maintained,
decreasing their stress and allowing for normal movement. Sixteen animals can be studied at one
time.
The old CLAMS is located in a research animal building slated for destruction in 2021; the old unit
will need to be dismantled and reconstructed in another building, then undergo recalibration
before returning to service, which will disrupt ongoing studies. A new CLAMS-HC could be
installed in another animal research building, undergo calibration and be in use before the old unit
is taken down, preventing disruption to ongoing work.

Public health relevance
Project Narrative A 2020 model Comprehensive Laboratory Animal Monitoring System-Home Cage (CLAMS-HC) will be employed as a core instrument to support the animal research program at the VA Puget Sound. Eleven funded investigators will actively use the CLAMS-HC with animal models that provide pre-clinical data essential for development of treatments, preventions, and cures for problems that significantly impact the Veteran population. An Oversight Committee of three Major Users and one non-user will coordinate equitable sharing of the unit, as well as arrangements for maintenance and repair as needed. No renovations are required to accommodate the instrument, which will be located in the animal research facility.